Retrograde transmission of pathogenic TDP-43 to the CNS

Project Summary/Abstract
TDP-43 is a common protein found aggregated in multiple neurodegenerative diseases and myopathies. TDP-
43 is a ubiquitously expressed RNA-binding protein that is primarily localized in the nucleus but relocates to the
cytoplasm under conditions of cellular stress, forming stress granules in neurons and myo-granules in skeletal
muscle. Normally TDP-43 returns to the nucleus when the stress is resolved, but through unknown disease
mechanisms misfolded TDP-43 remains in the cytoplasm as phosphorylated insoluble aggregates. Studies
have shown that TDP-43 forms amyloid-like oligomers which are capable of self-templated conversion in which
the misfolded protein causes its native counterpart to become misfolded, leading to propagation of the
aggregate pathology. The misfolded aggregation-prone proteins, referred to as proteopathic seeds, are
capable of cell-to-cell transmission through connected neuronal networks. In some diseases such as
multisystem proteinopathy, patients have TDP-43 aggregation in both skeletal muscle and neurons. In these
cases, myopathy symptoms begin several years prior to the onset of dementia. Therefore, the central
hypothesis behind this proposal is that TDP-43 is capable of self-templated conversion in skeletal
muscle and transmission to the central nervous system (CNS) to cause neurodegeneration. In order to
test this, TDP-43 isolated from human skeletal muscle myo-granules will first be tested for the ability to
undergo self-templated conversion in vitro using a thioflavin assay and a TDP-43 FRET sensor line. Then, the
isolated TDP-43 or recombinant TDP-43 seeds will be injected into the hindlimb muscles of wild type mice and
mice expressing TDP-43 with a mutated nuclear localization signal which causes increased cytoplasmic TDP-
43 expression. Mice will be monitored for motor or cognitive changes and sacrificed at specific time points
following proteopathic seed injection. Skeletal muscle will be examined for signs of local transmission and
pathology to confirm whether seeds can propagate in the environment of a myofiber. Additionally, the spinal
cord and brain will be examined for signs of TDP-43 pathology to determine whether intramuscular injected
TDP-43 proteopathic seeds can lead to transmission of TDP-43 proteinopathy to the CNS. To confirm muscle-
to-neuron transmission of TDP-43 seeds on a shorter timeline, primary mouse myoblasts expressing
fluorescently-tagged TDP-43 will be treated with proteopathic seeds and then co-cultured with primary mouse
neurons. The neurons will be monitored for fluorescent TDP-43, indicating seeding. If successful, the proposed
experiments will significantly improve the understanding of TDP-43 proteinopathy and whether it can spread
from the periphery to the CNS. This has the potential to greatly impact the diagnosis methods and treatment
options for neurodegenerative diseases. The successful completion of these aims as well as the training plan
provided will prepare the applicant to become an independent investigator in the field of protein aggregation
and neuromuscular disease.

Public health relevance
Project narrative TDP-43 aggregation is a common feature of many neurodegenerative diseases and myopathies. In this proposal I will isolate TDP-43 aggregates from skeletal muscle and test the hypothesis that muscle-derived TDP-43 aggregates can be transmitted in a retrograde manner to the brain. The proposed experiments have the potential to change the current understanding of the spread of pathology in several neurodegenerative diseases.